Training Core

Contact PD/PI: Salusky, Isidro B. NRSA-Training-001 (081)
Training Core Abstract
The broad goal of KUH-ART is to prepare our trainees to become leaders in cutting edge research in the
nephrology, urology and hematology areas. Our trainees will have either a clinical background or basic
science background combined with an interest in solving medically relevant questions in the KUH area. UCLA
KUH-ART will consolidate existing fragmented research training programs under one umbrella and create a
larger regional entity where trainees are part of an interactive cohort. The Specific Aims of the KUH-ART are:
1. Guide trainees in developing a strong foundation of knowledge in biological and health sciences relating to
different aspects of kidney, benign urologic and benign hematologic diseases.
2. Provide individualized hands-on mentored research training in each trainee’s focus area of basic,
translational, clinical or computational research.
3. Develop trainees’ scientific writing and communication skills for presentations, publications, and grants (see
Professional Development Core).
4. Maintain an interactive and supportive academic environment that promotes the development of team
research skills and collaborative experience needed for successful, independent scientific careers as
members and leaders of interdisciplinary teams.
5. Develop a KUH community through a versatile instructional and mentoring platform geared to the trainees,
mentors, the KUH scientific community and other research stakeholders at UCLA and nation-wide (see
Networking Core).
6. Devise and implement comprehensive tracking and ongoing evaluation in multiple areas of the program by
structured feedback from trainees, mentors, Internal and External Advisory Boards and NIDDK to identify
weaknesses and institute continuous quality improvement.
We aim to prepare outstanding pre- and postdoctoral scholars for research careers in benign KUH and allied
disciplines, promote multidisciplinary team research, and expand research workforce with both physicians and
non-clinician investigators pursuing or newly attracted to KUH research. Our goal is to attract an outstanding
group of pre- and postdoctoral applicants who seek a cross-training experience across the research spectrum
from basic sciences and translational medicine to health services and informatics. We have carefully selected
56 outstanding mentors who have a record of commitment to biomedical research training in the KUH and related
areas. The proposed new UCLA KUH-ART integrates and mutually potentiates the previously fragmented
research training and career development enterprise at UCLA and affiliated institutions. Ultimately, our graduates
will accelerate the volume, pace, and translation into practice of scientific discoveries and innovations that
improve the care and outcomes of patients across the lifespan, from children to the elderly.
Project Summary/Abstract Page 300
Contact PD/PI: Salusky, Isidro B. NRSA-Training-001 (081)
Training Core References Cited
1. National Institutes of Health. Physician-Scientist Workforce Working Group Report Bethesda, MD2014
[updated Jun; cited 2020 April 3]1-123]. Available from:
https://acd.od.nih.gov/documents/reports/PSW_Report_ACD_06042014.pdf.
2. Valantine HA, Collins FS. National Institutes of Health addresses the science of diversity. Proc Natl
Acad Sci U S A. 2015;112(40):12240-2. Epub 2015/09/24. doi: 10.1073/pnas.1515612112. PubMed
PMID: 26392553; PMCID: PMC4603507.
3. Kaiser J. Biomedical research: The graying of NIH research. Science. 2008;322(5903):848-9. Epub
2008/11/08. doi: 10.1126/science.322.5903.848. PubMed PMID: 18988821.
4. Matthews KRW, Calhoun KM, Lo N, Ho V. The aging of biomedical research in the United States. PLoS
ONE. 2011;6(12):e29738. doi: 10.1371/journal.pone.0029738. PubMed PMID: 22216352; PMCID:
PMC3247288.
5. Daniels RJ. A generation at risk: Young investigators and the future of the biomedical workforce. Proc
Natl Acad Sci U S A. 2015;112(2):313-8. Epub 2015/01/07. doi: 10.1073/pnas.1418761112. PubMed
PMID: 25561560; PMCID: PMC4299207.
6. Wong MD, Guerrero L, Sallam T, Frank JS, Fogelman AM, Demer LL. Outcomes of a Novel Training
Program for Physician-Scientists: Integrating Graduate Degree Training With Specialty Fellowship.
Journal of graduate medical education. 2016;8(1):85-90. Epub 2016/02/26. doi: 10.4300/jgme-d-15-
00135.1. PubMed PMID: 26913109; PMCID: PMC4763397.
7. Fogelman AM. Strategies for training generalists and subspecialists. Ann Intern Med. 1994;120(7):579-
83. Epub 1994/04/01. doi: 10.7326/0003-4819-120-7-199404010-00009. PubMed PMID: 8116997.
8. Gilliland CT, White J, Gee B, Kreeftmeijer-Vegter R, Bietrix F, Ussi AE, Hajduch M, Kocis P, Chiba N,
Hirasawa R, Suematsu M, Bryans J, Newman S, Hall MD, Austin CP. The fundamental chracteristics of
a translational scientist. ACS Pharmacol Transl Sci. 2019;2(3):213-6. Epub 2020/04/08. doi:
10.1021/acsptsci.9b00022. PubMed PMID: 32259057; PMCID: PMC7088880.
9. Garmire LX, Gliske S, Nguyen QC, Chen JH, Nemati S, JD VANH, Moore JH, Shreffler C, Dunn M.
THE TRAINING OF NEXT GENERATION DATA SCIENTISTS IN BIOMEDICINE. Pacific Symposium
on Biocomputing Pacific Symposium on Biocomputing. 2017;22:640-5. Epub 2016/11/30. doi:
10.1142/9789813207813_0059. PubMed PMID: 27897014; PMCID: PMC5425257.
10. Berk RA, Berg J, Mortimer R, Walton-Moss B, Yeo TP. Measuring the effectiveness of faculty
mentoring relationships. Academic medicine : journal of the Association of American Medical Colleges.
2005;80(1):66-71. Epub 2004/12/25. doi: 10.1097/00001888-200501000-00017. PubMed PMID:
15618097.
11. Mullikin EAB, L.L.; Betz,N.E. Assessing Research Self-Efficacy in Physician-Scientists: The Clinical
Research APPraisal Inventory. Journal of Career Assessment. 2007;15(3):367-87. doi:
10.1177/1069072707301232.
12. Romanick M, Ng K, Lee G, Herbert M, Coller BS. The Rockefeller University Graduate Tracking Survey
System. Clinical and translational science. 2015;8(4):326-9. Epub 2014/11/14. doi: 10.1111/cts.12238.
PubMed PMID: 25393695; PMCID: PMC4430469.
References Cited Page 301